CBC SMALL MOLECULE CHEMICAL REPOSITORY CONTRACT OPTION1, HHSN261201000079C, DTP-14-052, N02-CM-2010-00079,9/30/814 - 9/20/15, DSCB. OPTION 1 (9/30/2014 - 9/29/2015)

Establish a small chemical repository for the NCI chemical Biology Consortium (CBC).